Statistical Data Enclave Core

Core E: Data Enclave (Core Director, McCabe). This core has five objectives: (i) Maintain its current virtual secure data enclave, a Citrix-based system, and expand as warranted to meet the demand for strong data protection; (ii) Support for the data manager who controls access to the PARC facilities and monitors use, installs new data sets on the Citrix servers, and assists users new to the system; (iff) Provide consultation to other NIA P30 data enclaves on the rationale, configuration, and options of a Citrix system; (iv) In collaboration with NORC, develop encryption standards for varying degrees of data protection; and (v) Organize a Citrix meeting in Yr 3 for other P30 Centers, including those located in a Medical environment.